Dissecting and engineering reversible cell cycle states

7. PROJECT SUMMARY/ABSTRACT
Numerous diseases across organ systems as well as the deleterious effects of aging are attributable to the
loss of terminally differentiated cells that facilitate organ function. In these cases, there is no active stem cell
population capable of generating new functional cells. Moreover, any functional cells that remain cannot
replace lost cells as the former have permanently exited the cell cycle as part of their differentiation process. A
means of making terminally differentiated cells re-enter the cell cycle would dramatically alleviate and
potentially cure these disease states. In principle, cellular differentiation does not necessitate cell cycle exit.
Indeed some differentiated cell types, such as hepatocytes and lymphocytes, retain the ability to re-enter the
cell cycle. These cell types are considered to be quiescent rather than terminally differentiated. Some of the
extracellular signals that drive quiescent cells back into the cell cycle as well as the pathway for cell cycle
entry, the Cyclin D-Cdk4,6 pathway, have been defined. However, it is unclear what allows a quiescent cell to
receive these signals and reactivate the Cyclin D-Cdk4,6 pathway while a terminally differentiated cell cannot
do so. As such, the difference between terminally differentiated cells and quiescent cells is a functional
classification lacking a molecular explanation. Although mammalian cell culture models have provided tractable
systems for investigating quiescence, they have failed to recapitulate the complexity of cell cycle regulation in
tissues. There is therefore a need to study quiescence in an organismal context in order to provide a
comprehensive understanding of this state and facilitate its translation to regenerative medicine. This project
will establish the mouse liver as a tractable physiologic system to understand the reversibility of the quiescent
state ultimately in order to confer this ability to terminally differentiated cells and enable their proliferation in the
setting of disease. The approach will consider two non-mutually exclusive means of poising the Cyclin D-
Cdk4,6 pathway for reactivation: direct modulation of the pathway itself or involvement of a factor extrinsic to
this cascade. Aim 1 will determine whether there are functionally relevant differences in the activity of Cyclin D-
Cdk4,6 pathway components in quiescent hepatocytes compared to other cell cycle states in tissues. Aim 2 will
establish the first genome-wide, loss-of-function screen in the liver to identify any genes outside of this
pathway that are required for the reversibility of quiescence. Finally, aim 3 will define conserved molecular
features of quiescence by determining which features identified in aims 1 and 2 are also required for the
reversibility of this state in lymphocytes. Together, these experiments will elucidate the core molecular
signature of quiescence and thus the distinction between quiescence and terminal differentiation in tissues.
Core factors would then be introduced into terminally differentiated cells and evaluated for their ability to confer
proliferative capacity. These findings will not only fill a critical gap in our understanding of the mammalian cell
cycle but also unlock a novel means of treating myriad diseases currently lacking effective therapy.

Public health relevance
8. PROJECT NARRATIVE The loss of terminally differentiated cells critical for organ function underlies the lifelong morbidity associated with stroke, neurodegeneration, heart attack, hearing loss, and a plethora of other diseases. This project aims to understand what enables some cell types, known as quiescent cells, to re-enter the cell cycle and proliferate while terminally differentiated cells cannot. Establishing this distinction opens the possibility of introducing the features that define quiescent cells into terminally differentiated cells to enable their proliferation and alleviate numerous diseases currently without effective treatment.